Screening for B. burgdorferi borreliacidal/borreliastatic compounds

The NCATS Early Translation Branch (ETB) hosts a broad and comprehensive program for the discovery of drug candidates directed towards rare diseases and pharmacological tools to probe the function of the human genome. ETB conducts research to understand the underlying principles driving the translation of basic research discoveries into tangible improvements in human health.

During the reporting period, the collaborative team has begun assay optimization utilizing wildtype and recombinant Borrelia stocks (with stable luciferase expression). Assay miniaturization work is ongoing, with a view to developing a high-throughput amenable screening assay using both BacTiterGlo and luciferase readouts.